Administrative Supplement: A Workstation for Biomolecular Simulations

Project Summary/Abstract
High performance computing (HPC) has become an indispensable resource for scientific research in diverse
fields including deep learning, bioinformatics, and molecular simulation. In the parent award (Grant No.:
1R16GM146633), Dr. Negin Forouzesh (PI) proposed to design, develop, and test a Physics-Guided Neural
Network (PGNN) model for improving the accuracy of protein-ligand binding free energy using implicit solvent
models. Recent results on more than 300 protein-ligand complexes demonstrate that the proposed PGNN model
can successfully improve the “accuracy” of the pure physics-based model. In addition, the “interpretability” and
“transferability” of the model have been boosted compared to the purely data-driven model. In this proposal, the
PI requests the purchase of a workstation to (1) run molecular dynamics (MD) simulations, (2) train deep learning
models, and (3) run a massively parallel implementation of an optimization algorithm. The requested storage is
for saving protein-ligand structures, MD trajectories, source codes, student theses, and manuscripts. The new
equipment will enable the student assistants to run HPC simulations efficiently and will improve the quality and
extent of research in the Biomolecular area at Cal State LA.

Public health relevance
Project Narrative The parent award aims to leverage state-of-the-art data-driven models for accurate estimation of protein-ligand binding affinity that has wide applications in drug discovery. In this proposal, a modern workstation is requested in order to run machine learning models and molecular dynamics simulations more efficiently. The outcome of this research will improve the current understanding of protein-ligand interactions and will benefit the computer-aided drug design.